Lowering the burden of medical translation by enabling healthcare professionals as human editors of machine translations

Language access solutions in healthcare have focused almost exclusively on the provision of verbal medical interpretation, despite federal and state laws that mandate translation of written information for patients with limited English proficiency (LEP). In recent years, machine translation (MT) has made significant strides, but when it comes to mission-critical technical materials such as healthcare information, the accuracy rate of machine-only translations plummets. Thus, experts recommend MT as a starting point for translating health-related material then supplementing with human quality assurance editing. However, coordinating machine translation with human editors who have technical medical knowledge is a challenge, especially for less commonly supported languages. Translation vendors currently pass on the associated costs of human assistance to healthcare institutions. The Canopy Translate project will address these deficits by implementing a novel, human-assisted machine translation (HAMT) process. The envisioned workflow management platform will leverage MT engines to expedite the initial rendering of source documents into a target language, then invite healthcare professionals with the requisite fluency to apply human editing to the machine-generated translation. The contributors, who will gain complimentary access to our Medical English eLearning courses as an incentive for their participation, will complete the editing task through gamified learning exercises. In Phase I, we will test the feasibility of this hybrid HAMT approach for medical content. Upon meeting feasibility benchmarks, we will advance to Phase II, during which we will create a minimum viable product, encompassing several novel natural language processing (NLP) algorithms, and evaluate the translation output according to a set of quality benchmarks. If successful, this project will significantly improve the availability, speed, and cost-effectiveness of producing language-concordant health content, with potential to improve health outcomes in LEP populations.

Public health relevance
Despite a number of federal and state laws that mandate translation of written information for patients with limited English proficiency, this aspect of language access has been largely neglected. The current process for translation seldom supports all languages and the power of machine translation for medical documents has not been fully harnessed due to lack of infrastructure for human oversight, creating significant cost and time burdens. This innovation will leverage medical personnel with applicable fluencies to complete learning exercises as they edit machine translations in order to improve the availability, speed, and cost-effectiveness of creating translated medical content.